Integrating Low-Cost Paper-Based Devices and Personalized Immunotherapeutics to Treat Triple Negative Breast Cancer

Integrating Low-Cost Paper-Based Devices and Personalized
Immunotherapeutics to Treat Triple Negative Breast Cancer
Summary
After a breast cancer patient has an initial appointment with her clinician, one
possible outcome is that the cancer tests positive for one or more clinically
significant cell surface “biomarkers”, most notably estrogen receptor (ER),
progesterone receptor (PR), or HER2. In this relatively good scenario, the patient would likely be prescribed
a personalized therapy such as a hormone therapy (in the case of ER+ and/or PR+ cancers) or with drugs
that specifically target HER2+ cells (e.g. the monoclonal antibody, mAb, Herceptin™). These personalized
drugs are less toxic than general anti- cancer drugs such as chemotherapeutic cocktails.
In a different, and relatively dire scenario, a patient is told she has “triple negative” breast cancer
(ER-, PR-, HER2-), meaning her cancer cells lack hormone receptors like ER or PR, and lack HER2. Triple
negative breast cancer (TNBC) represents 15-20% of all breast cancer cases, and disproportionately
affects minority populations. Without personalized therapies, this patient is now left to suffer through
treatment with non-targeted and toxic drugs (chemotherapeutics) that come with a host of debilitating side
effects. Commonly, drastic measures, such as mastectomy, are required in order to fully remove all tissue
that could serve as a source of, or substrate for, new tumors. The five-year survival outcomes of populations
that test positive for HR and/or HER2, and TNBC patients substantially differs as well. For patients who
test positive for HR and/or HER2 with regional breast cancer, five-year survival is ~82-89%, but 65% for
TNBC. Clearly, new technologies and approaches are required to target TNBC and provide these patients
the same therapeutic opportunities that patients that test positive for HR or HER2 biomarkers have.
Here, we propose a fundamentally different approach to personalized medicine, which will
dramatically change how we treat TNBC, particularly in lower income minority populations. We will
evolve small proteins to selectively bind a patient’s breast cancer cells, irrespective of the specific changes
to the cell surface that have occurred as a result of breast cancer. These proteins will be fused to other
proteins that provide stability in the body, and recruit antibodies from the patient’s serum to TNBC cells,
resulting in their targeted destruction. We will pair our TNBC-targeting immunotherapies (drugs that use
the immune system to destroy TNBC cells) with a low-cost paper-based platform, which will allow simple,
accessible, and routine assessment of our TNBC-targeting proteins, and allow clinicians to select which
members should make up a combination therapy. The diagnostic platform will also allow clinicians to
monitor the effectiveness of each member of the cocktail over the course of treatment (as cancer cells
mutate), and select alternative members and/or replacements when necessary.
Collectively, this work represents necessary and exciting advances in the integration of low-cost
approaches to TNBC-targeting, and personalized, drug discovery, and the optimization and monitoring of
these immunotherapeutic cocktails over the course of treatment.

Public health relevance
Narrative. Triple negative breast cancer (TNBC) is a particularly aggressive breast cancer subtype, disproportionately seen in African Americans, and in contrast to other breast cancer subtypes, there are no current targeted therapies. One goal of this research is to develop non-antibody protein-based targeted immunotherapeutics that are personalized for virtually any TNBC patient, and trigger immune cells to seek out and destroy TNBC cells. Protein immunotherapeutics are designed for long in vivo lifetime, which rival monoclonal antibodies, and use existing serum antibodies to kill TNBC cells. A second goal of this research is to develop a low-cost paper based diagnostic platform that will be used to rapidly identify which protein immunotherapeutics are best suited to serve as a combination therapy for a given TNBC patient, and monitor the therapeutic efficacy of the combination over the course of treatment.